Psychological consequences of medical transition in transgender youth

Project Summary/Abstract
Transgender youth experience higher levels of mental illness than their cisgender (i.e., non-transgender)
peers. One proposed contributor to these high rates of mental illness is the discordance transgender youth
experience between their bodies and appearances, on one hand, and their gender identities, on the other.
Medical organizations have suggested that endocrine interventions—specifically puberty suppression and
hormone therapy—can improve mental health in transgender youth by halting the development of gender-
incongruent secondary sex characteristics and producing gender-congruent secondary sex characteristics,
respectively. Yet legislators throughout the US have recently introduced bills that would ban transgender youth
from accessing puberty suppression and hormone therapy, asserting that these interventions are not
psychologically beneficial. Five studies to date have longitudinally examined the relationship between one or
both of these interventions and mental health in transgender youth. However, these studies have had relatively
small samples, none have been able to isolate the effects of endocrine interventions, none have included a
cisgender comparison group, and none have examined the mechanisms by which endocrine interventions
might improve mental health. The goal of the proposed research is twofold: (1) To examine the relationship
between gender-affirming endocrine interventions and mental health in transgender youth and compare the
mental health trajectories of transgender youth undergoing gender-affirming endocrine interventions to those of
their cisgender peers; and (2) To explore the mechanisms underlying the relationship between endocrine
interventions and mental health in transgender youth. To achieve these goals, I will measure mental health
(anxiety and depression, as well as self-esteem) and body image (dissatisfaction, surveillance,
depersonalization, and identity-appearance congruence) at three timepoints (before puberty suppression, after
puberty suppression, and after hormone therapy) in a large sample (n=204 for puberty suppression, n=188 for
hormone therapy) of transgender youth, as well as in two comparison groups (siblings, n=122, and unrelated
cisgender youth, n=204). This research will allow me to determine whether endocrine interventions might help
to reduce or eliminate mental health disparities between transgender and cisgender youth. I will conduct this
research within the Human Diversity Lab at Princeton University, with mentorship from the lab’s PI, Dr. Kristina
Olson (Sponsor), who runs the TransYouth Project, the world’s largest study of transgender youth who socially
transitioned at an early age. I will also receive training from Dr. Katie McLaughlin (Collaborator), a
developmental psychopathology expert at Harvard University, Dr. Robin Gomila (Consultant), a statistics
expert at Princeton, and Dr. Ian Marshall (Consultant), a pediatric endocrinologist at Rutgers University. This
fellowship will deepen my knowledge of developmental, clinical psychology, expand my methodological
toolbox, and enable me to establish a strong publication record.

Public health relevance
Project Narrative Transgender youth, who identify with a gender different from that which was assigned to them at birth, experience markedly high rates of mental illness. Endocrine interventions—namely, puberty suppression and gender-affirming hormone therapy—may reduce body dissatisfaction, body surveillance, depersonalization, and identity-appearance incongruence and decrease depression and anxiety as a result. The current project compares trajectories of body image and mental health in medically transitioning transgender adolescents and their cisgender (i.e., non-transgender) counterparts to determine whether and how endocrine interventions might help to eliminate mental health disparities between transgender and cisgender youth.